Microsimulation to Improve the Health and Wellbeing of Older Populations

ABSTRACT This workshop will be the first meeting to bring together multidisciplinary perspectives—including thought leaders in microsimulation, health economics, demography, health care reimbursement, health policy, decision analysis, and aging research—to discuss the application of microsimulation to address a range of topics in aging, including the impact of policies on the aging population. It will be a companion meeting held in the United States to the 8th World Congress of the International Microsimulation Association, and will be unique by focusing solely on the application of microsimulation to topics in aging. In addition to uniting aging researchers across multiple disciplines with domestic and international experts in microsimulation, our workshop will emphasize the inclusion of National Institute on Aging (NIA) investigators and trainees to expose this community to the utility and value of microsimulation. The workshop will have the following four aims: 1) Unite established and young investigators across multiple disciplines to discuss the application of microsimulation to address a broad range of salient topics in aging, identify gaps in knowledge that could be resolved using microsimulation, and identify barriers to its implementation and advancement. In doing so, we will build-out existing microsimulation models and expand the user base, thereby increasing the capacity and power of models and enabling them to more effectively guide the development of policies impacting older adults. 2) Engage the aging research community in the United States, especially NIA investigators and trainees, and increase their representation in the field of microsimulation. This will expose current and future leaders in aging research to the capacity and benefits of microsimulation, promote collaborations among the NIA research community, and encourage the application of microsimulation to existing NIA data sets (e.g., the Health and Retirement Study and its sister surveys from around the world) to generate new and innovative insights. 3) Develop a strategic action plan to set priorities for future studies. This plan will summarize workshop presentations and conclusions and provide a framework for future studies to expand on these findings and enhance the utility and capacity of dynamic microsimulation models. 4) Develop a Young Investigator Program to motivate a diverse group of students and young investigators to pursue careers in microsimulation and aging research. Our Program will allow for collaborative networking and exchange of knowledge and ideas among young and established investigators, with the goal of encouraging young investigators to pursue research careers related to microsimulation and aging, and ultimately submit grant proposals to NIA solicitations and contribute to the scientific literature. Through talks, sessions, and discussions, our workshop will expand the use of dynamic microsimulation models among the aging research community in the United States and advance the goals of NIA’s Strategic Plan by developing a strategic action plan and disseminating it to the public and scientific and policy communities, to ultimately inform future research, policies and interventions, and improve the health, wellbeing and independence of aging adults in the United States.

Public health relevance
PROJECT NARRATIVE This workshop will provide a collaborative environment for members of the microsimulation, economic, policy, demography, decision analysis, payer, and aging research communities to discuss the application of microsimulation to salient topics in aging. It is anticipated that this workshop will unify the United States aging research community, including investigators and trainees supported by the National Institute on Aging, with domestic and international experts in microsimulation, facilitate collaborations among these fields, and accelerate the implementation of microsimulation into aging research in the United States. Our multidisciplinary approach will provide critical new insights and a framework to build-out microsimulation models and expand users, thereby increasing the capacity and utility of microsimulation and enabling it to more effectively guide future research, policies and interventions that will improve the health, wellbeing, and independence of aging adults in the United States.